Pilot Projects and Trans-Network Activities

PILOT PROJECTS AND TRANS-NETWORK ACTIVITIES CORE
University of California and UT Southwestern Diversity Patient-Derived Xenograft (PDX) Development
and Trial Center (UCaTS) to Reduce Cancer Health Disparities
PROJECT SUMMARY/ABSTRACT
The goal of the Pilot Projects and Trans-Network Activities Core (PPTNAC) is to contribute to the achievement
of the University of Californiaand UT Southwestern Diversity Patient-Derived Xenograft (PDX) Development and
Trial Center (UCaTS) overall objectives of developing PDX trial strategies for preclinical testing of single agents
and drug combinations. This D-PDTC focuses on the predominant racial/ethnic minority populations residing in
California and Texas, namely, Latinos, African American [AAs] and Asian American/Native Hawaiian/Pacific
Islander [AANHPIs]. The focus will be on gastric cancer which disproportionately affect Latinos and all
populations of color, and lung cancer, which has a high burden in Latino and AANHPI women. Key personnel
for this Core include the PPTNAC Lead Moon S. Chen, Jr., who has successfully led PPTNAC in our ongoing
UCaMP PDX Development and Trial Center (PDTC), all Site PIs, Contact PI and Administrative Core Lead Luis
Carvajal-Carmona, and UCaTS Grant Administrator. As such, PPTNAC investigators reflect multiple relevant
disciplines that foster the evaluation of pilot studies and trans-network activities including cancer health
disparities, pre-clinical studies, pathology, and basic cancer research. PPTNAC will also facilitate the interaction
of UCaTS with NCI, PDXNet Data Commons and Coordinating Centers (PDCCC), other PDTCs, and non-
PDXNet investigators through funded projects. Specifically, the PPTNAC Aims are to: (1) Facilitate Internal Pilot
Projects; (2) Facilitate Cross-PDXNet Activities (Pilot Studies Development and Evaluation); and (3) Engage
Non-Network Investigators; and (4) Share Innovative Technologies using PDXs (Collaboration with non-PDXNet
investigators).

Public health relevance
PILOT PROJECTS AND TRANS-NETWORK ACTIVITIES CORE NARRATIVE The University of California and University of Texas Southwestern Diversity Patient-Derived Xenograft (PDX) Development and Trial Center leverages the collective strengths of six NCI- Comprehensive Cancer Centers to create minority patient cancer models and characterize targeted treatment responses to stomach and lung tumors. The Pilot Projects and Trans-Network Activities Core will administer NCI-funded pilot project opportunities to facilitate interactions among UCaTS, the PDXNet Consortium, and non-PDXNet investigators. Additionally, this Core will coordinate the development of standard operating procedures and develop methods of experimental validation and reproducibility that will be shared within the Trans-Network and in collaboration with non-Network projects. Through UCaTS activities, we expect to extend our large repository to facilitate the discover of new therapies that could impact vulnerable racial and ethnic minority cancer patients.